Impact of Music Improvisation Training on Brain Function and Cognition among Older Adults

ABSTRACT
Approximately 5.8 million adults age 60 and over in the United States live with Alzheimer disease and related
dementias (AD/ADRD) at a cost of $290 billion per year. Older adults with mild cognitive impairment (MCI), an
intermediate stage between typical aging and dementia, are 3-5 times more likely to progress to AD than those
with normal cognition. Late-life engagement in cognitively challenging activities is associated with decreased
risk of cognitive decline, and there is a need to address cognitive inactivity. Music interventions are a
promising strategy to address late-life cognitive inactivity. Music training can change brain structure and
function in non-musician adults, thereby leading to cognitive, perceptual, and psychosocial advantages. These
changes in cognitive function are thought to occur because the multimodal, complex nature of music facilitates
training-induced neural plasticity. However, the mechanisms are not yet understood, and most studies used
traditional or rote keyboard training techniques. Music training based on improvisation principles—the
spontaneous generation of musical melodies and rhythms—will likely have more potent effects on cognition
and brain function. Improvisation facilitates cognitive flexibility, self-monitoring, novel idea generation,
execution of unplanned motor sequences and entrance into a state of flow. Biologically, improvisation is
associated with distinct neural patterns involving activation of prefrontal networks and other brain networks that
are affected by aging. As a mechanism of behavior change, it is likely that improvisation training will uniquely
improve self-regulation (the ability to monitor and control one's own behavior, emotions, or thoughts and
modify to situational demands). Yet, no research has tested whether improvisation training can improve self-
regulation and facilitate maintenance of cognitively challenging activities among older adults with and without
MCI. This project will develop and test the effects and mechanisms of a music improvisation training
intervention on self-regulation of older adults with and without MCI. Our overall hypothesis is that improvisation
training will lead to improvements in self-regulation, compared to controls, and that improvisation training will
be associated with specific changes in prefrontal brain networks and ultimately cognitive engagement. Our
project has two phases. In the R61 phase, we will develop a music improvisation training intervention that aims
to improve self-regulation among older adults with and without MCI and conduct a 2-arm randomized pilot
study to (i) examine feasibility and acceptability of the intervention and study methods and (ii) determine its
effects on the hypothesized mechanism of self-regulation. If milestones are met, we will proceed to the R33
phase and conduct a randomized mechanistic trial to examine the effects of the intervention, compared to an
attention control, on self-regulation and cognitive engagement among older adults with and without MCI. The
findings from this study will improve our understanding of the underlying mechanisms of how music training
interventions can facilitate behavior change to maintain health of older adults.

Public health relevance
Project Narrative Music training can change brain structure and function in non-musician older adults age 60 and over. The goal of our project is to examine whether a music improvisation training intervention for older adults with and without mild cognitive impairment can improve cognition and brain function and facilitate late-life engagement in cognitively challenging activities.